Meso-microscale physiology and dynamics of slow network fluctuations

ABSTRACT: Neural networks orchestrate behavior across multiple timescales and are disordered in numerous
developmental, neurological, and psychiatric disorders. Here we use intracranial EEG recording in humans
(iEEG) to address the role of slow brain network fluctuations (SBNFs) and local cortical activation in the neural
circuits supporting external attention and attention to our internal thoughts. Notably, attention to inner thoughts
occupies up to fifty percent of our awake time but has received considerably less research focus which we will
address in the Conte Center. We focus on differential interactions between the default mode network (DMN)
and the fronto-parietal attention networks (FPCN) in support of these two core attention states. Local neural
activation is measured with broadband high frequency activity (BHA; 70-200 Hz) and single-unit activity (SUA).
Inter-areal network interactions are assessed using connectivity metrics including phase slope index, single-
trial HFA onsets, Granger causality, directional phase amplitude coupling, representational similarity and
mutual information. To examine slow fluctuations of internally versus externally directed attention across
temporal and cognitive scales, we start with well-controlled paradigms and systematically increase
experimental naturalism across three AIMS. AIM 1 employs structured tasks including switching between
external and internal attention states with a focus on the role of anterior insula and posterior cingulate in
switching. An intermodal auditory-visual attention task probes attention and lapses. In another condition we
deliver the same intermodal streams while the subject paces and slows down breaths to increase vagal
afferent firing, providing iEEG evidence of interoception and its effects on attention networks. AIM 2 uses a
more naturalistic paradigm entailing passive viewing of movies. EOMs, alpha oscillations, BHA and
pupillometry indexes drifts away from active attention to internal thought. We use a post-movie recognition task
to confirm lapses of external attention to the movies and assess the changes in the properties of interactions
between the DMN and FPCNa and FPCNb networks. AIM 3 uses experience sampling coupled with
continuous iEEG recording across multiple days. Subjects are queried about their internal mental state (on-
task: reading a book, talking to a family member or health provider) or off-task and mind-wandering as further
determined by the behavioral metrics also used in P1. This task provides a powerful test of the networks
supporting external versus internal attention in the most naturalistic environment one can achieve in an
epilepsy monitoring unit. During internal thought we assess freely moving thoughts that drift from one topic to
another, deliberately constrained thoughts focusing on an overarching goal, and automatically constrained
thoughts drawn to personally or affectively salient topics. Our findings coupled with the EEG and fMRI results
in P1 and the macaque data in P3 will improve our understanding of how SBNFs underpin and support both
normal cognition and disordered attention in neuropsychiatric disorders.